Developing an Intraoperative EEG-Guided Precision Anesthesia Management System to Prevent Postoperative Delirium in Elderly and Patients at Risk for Alzheimer's & Related Dementias

Each day in the United States, over 100,000 patients receive general anesthesia, with about 40% being
aged 60 and above. The current practice of general anesthesia is prone to over-sedating patients, either
due to the lack of brain monitoring or using brain monitors with inaccurate indices. Over-sedation (at 28%
incidence) contributes to post-operative delirium (POD) in elderly population (≥65yrs). Notably, 11% of
these elderly patients suffer from Alzheimer’s Disease and Related Dementias, placing them at an even
higher risk of POD. PASCALL was founded to introduce a novel neuroscience-based EEG-guided
personalized anesthetic management. In our original grant, AG066325, we achieved a) (AG066325 Aim
1,2) the design, development, and FDA 510(k) pre-market clearance of a wireless anesthetic brain
monitor, designated as M0 and b) (AG066325 Aim 3) the development of personalized algorithms to
monitor anesthetic brain state in aging, dementia, and Alzheimer’s disease patients.
In this grant, we propose concrete steps to commercialize M0 and the personalized algorithms
developed in AG066325, collectively designated as PASCALL M1. We realize this innovation through 4
specific aims: Aim 1: Ensure the accuracy of M1 index in aging & ADRD patients by performing
verification and validation on proprietary data sets (N=1597 retrospective, N=564 prospective); Aim 2:
Implement an integrated IP, clinical and marketing strategy for M1; Aim 3: Accelerate the pathways to
regulatory clearance and reimbursement for the M1 by: requesting FDA Breakthrough Device
designation, evaluating suitable CMS programs, and existing modifying circumstances codes code; and
Aim 4: Optimize the potential for adoption and effective use of the device by: conducting human factor
testing with anesthesia caregivers in diverse hospital settings, and incorporate their feedback to refine
the hardware and software for an improved user experience; creating an extensive education program
that includes essential scientific knowledge, clinical simulations, and interactive peer-to-peer training to
increase device accessibility; and optimizing manufacturing processes to an industry-aligned 65 percent
device gross margin. If successful, this effort will bring neuroscience-based precision anesthesia care to
millions of older patients, saving Medicare ~$44,000 per patient per year and eliminating needless
suffering including long-term functional and cognitive disability.

Public health relevance
PASCALL is addressing the high incidence of post-operative delirium (POD) in the elderly population (≥60 years-old), particularly those with pre-existing or undiagnosed dementia or Alzheimer's disease, caused by the lack of accurate neuromonitoring. PASCALL aims to develop an FDA “Breakthrough” system that is effective, labor-efficient, scalable, and reimbursable for POD prevention through EEG-guided anesthetic management. The system can reduce POD upto 50 percent to 12.5% from the 25% baseline POD incidence, generate significant saving for Medicare (~$44,000 per patient per year) and eliminating needless suffering including long-term functional and cognitive disability.